REGIONAL FATTY ACID METABOLISM IN HUMANS--HEPATIC FFA DELIVERY IN NIDDM

To determine whether the liver is exposed to excessive amounts of fat present in the bloodstream in obese and non-obese individuals with and without NIDDM.